Expanding the therapeutic capacity of Saccharomyces cerevisiae var. boulardii for the treatment of gastrointestinal infections

ABSTRACT
Gastrointestinal (GI) disease is a significant global problem, causing 3 million hospitalizations in the US alone.
Conventional antimicrobial treatment of GI infections present challenges such as selection of antibiotic resistance
and off-target interactions with commensal microbes. GI diseases are uniquely challenging to treat with protein-
based therapies because they often cannot withstand the harsh and rapidly changing environment of the GI
tract, which includes a rich collection of proteases. I hypothesize that an engineered probiotic, Saccharomyces
cerevisiae var. boulardii (Sb), can deliver anti-infective, protein-based therapies to the GI tract to treat the key
enteric pathogens Clostridioides difficile (Cd) and enterotoxigenic Bacteroides fragilis (ETBF). Next-generation
therapies targeting Cd and ETBF, including antimicrobial peptides (AMPs), toxin-neutralizing binding domains,
and anti-virulence proteins are in development and are amenable to Sb-based expression and secretion. Sb
maintains viability throughout the mammalian GI tract and can be modified with sophisticated genetic engineering
tools developed for the model yeast Saccharomyces cerevisiae. Herein, I propose to expand upon a genetic
toolbox I have begun establishing to achieve finely tuned expression and secretion capacity from Sb in the con-
text of the mammalian GI environment and use this toolbox to modulate the expression of a panel of anti-infective
therapeutics targeted to either Cd or ETBF. I will thoroughly characterize a panel of Sb strains carrying these
therapies in terms of efficacy, tolerability, and impact on the host microbiome in the context of enteric infection.
The rationale for this proposal stems from i) the need for improved and controlled delivery strategies for anti-
infective protein therapies to treat GI infections, and ii) the extensive potential for Sb, which has inherent anti-
pathogen qualities, to be genetically modified for production and delivery of a large variety of therapeutic pay-
loads. My central motivation is to demonstrate the capacity for engineered Sb to eradicate the clinically significant
gut pathogens Cd and ETBF through therapeutic delivery systems that are both tunable and combinatorial. This
will be achieved through two aims: 1) define and expand the therapeutic capacity of Sb specifically in the mam-
malian gut environment by building a genetic toolbox of secretion constructs with varying secretion capacities of
a panel of anti-Cd and anti-ETBF therapies with distinct mechanisms of action, and 2) demonstrate that engi-
neered Sb is capable of selectively targeting the Cd and ETBF in murine models of infection. These experiments
are significant as they generate novel treatment regimens for enteric infections, including against Cd which has
significant morbidity and mortality worldwide, and for ETBF which has no clinically approved, targeted therapy
available. This proposal is innovative as it will develop Sb as a carrier of anti-Cd and anti-ETBF AMPs for the
first time and extensively define the impact of this therapeutic system on the host microbiota as well as the target
pathogen. Finally, this proposal is impactful as it strives to develop a safe, non-invasive, and targeted treatment
for major GI infections, and can be readily adapted to treat other maladies of the GI tract.

Public health relevance
PROJECT NARRATIVE Targeted strategies to combat enteric infections are needed to overcome deficiencies with conventional antibiotic treatment such as access and stability in the GI tract, antibiotic resistance, and collateral damage to the native microbiome. Within this proposal, I will (1) define and expand the expression capacity of Saccharomyces cerevisiae var. boulardii (Sb)-produced anti-infective therapeutics in conditions mimicking the gut environment, and (2) establish tolerability and treatment outcomes of engineered Sb carrying a variety of anti-pathogen payloads as single agents or in combination. This work will generate innovative engineered probiotic therapies that can directly and safely mitigate the specific pathogens Clostridioides difficile and enterotoxigenic Bacteroides fragilis from the mammalian gut.